DiCAYA: South Carolina Youth (Component A)

PROJECT SUMMARY
Between 2001 and 2009, the multi-site SEARCH for Diabetes in Youth study documented marked increases in
the incidence and prevalence of type 1 diabetes (T1D) and type 2 diabetes (T2D) among youth. These trends
were largely driven by increased incidence rates in racial and ethnic minorities. Ongoing surveillance of
diabetes diagnosed in youth is essential to inform health care systems and generate testable hypotheses
related to the natural history of diabetes in youth, but it cannot be accomplished through existing national
survey-based surveillance efforts because of the rarity of diabetes in youth. Therefore, in response to RFA-DP-
20-001, Component A, we propose the South Carolina DiCAYA Youth study, which will ascertain newly-
diagnosed incident diabetes cases statewide throughout the study period. Our approach is informed by almost
20 years of experience in South Carolina that allows us to conduct diabetes surveillance work in youth in a
highly efficient manner, relying on a novel 2-step approach developed by our team which builds on electronic
health record (EHR) data. Our specific aims are: Aim 1: To ascertain newly-diagnosed cases of incident
diabetes in youth < 18 years of age in 2020 - 2024 in order to describe diabetes incidence in South Carolina,
by age, sex, race/ethnicity, and diabetes type. Aim 2: To provide annual estimates of the prevalence of
diabetes in youth < 18 years, by age, sex, race/ethnicity, and diabetes type, using mathematical modeling and
the ascertained incidence data. South Carolina is uniquely positioned to contribute to the DiCAYA surveillance
effort by employing our well-established surveillance infrastructure that has been refined for optimal efficiency
while maintaining our exceptional levels of scientific rigor and ascertainment completeness. Moreover, we are
comprised of a highly-experienced, collaborative and multi-disciplinary investigative team. Last but not least,
South Carolina’s location in the South Atlantic census division and high proportion of non- Hispanic black
residents will be critical to guaranteeing the representativeness of the overall DiCAYA surveillance effort, as
South Carolina has contributed 21% of all incident T1D cases (48% of non-Hispanic black T1D) and 32% of all
incident T2D cases (70% of non-Hispanic black T2D) to surveillance conducted by SEARCH. Thus, the well-
established and highly- productive South Carolina team is uniquely positioned to provide critical information on
the prevalence and incidence of diabetes in youth.

Public health relevance
NARRATIVE Diabetes mellitus is one of the most common chronic diseases in the United States and the prevalence seems to be increasing. South Carolina DiCAYA Youth is a state-wide, population-based surveillance effort tailored to estimate diabetes incidence and prevalence in children and adolescents under the age of 18 by type of diabetes, age, sex, race/ethnicity, and geography, and builds on the SEARCH for Diabetes in Youth registry effort in South Carolina and nationally. Understanding the burden of diabetes in youth will assist with future health care planning and public health prevention efforts.